Novel machine learning approaches for improving structural discrimination in cryo-electron tomography-Administrative Supplement

Project Summary Cellular cryo-electron tomography (Cryo-ET) has made possible the observation of cellular organelles and macromolecular complexes at nanometer resolution with native conformations. The rapid increasing amount of Cryo-ET data available however brings along some major challenges for analysis which we will timely address in this proposal. We will design novel data- driven machine learning algorithms for improving structural discrimination and resolution. In particular, we have the following specific aims: (1) We will develop a novel Autoencoder and Iterative region Matching (AIM) algorithm for marker-free alignment of image tilt-series to reconstruct tomograms with improved resolution; (2) We will develop a saliency-based auto- picking algorithm for better detecting macromolecular complexes, and combine it with an innovative 2D-to-3D framework to further improve structure detection accuracy; (3) We will design an end-to-end convolutional model for pose-invariant clustering of subtomograms. This model will produce an initial clustering which will be refined by a new subtomogram averaging algorithm that automatically down weights subtomograms of noise and little contribution; (4) We will perform experimental evaluations by using previously reported bacterial secretion systems and mitochondrial ultrastructures datasets to improve the final resolution. Implementing algorithms in Aims 1-3, we will develop a user-friendly open-source graphical user interface α-tom to directly benefit the scientific community. α-tom will be systematically compared with existing software including IMOD, EMAN2, and Relion on simulated and benchmark datasets. To facilitate distribution, α-tom will be integrated into existing software platforms Scipion and TomoMiner. Our data-driven algorithms and software not only will facilitate and accelerate the future use of Cryo- ET, but also can be readily used on analyzing the existing large amounts of Cryo-ET data to improve our understanding of the structure, function, and spatial organization of macromolecular complexes in situ.

Public health relevance
Project Narrative This project will create a system of machine learning algorithms to accelerate and facilitate the use and re-use of the rapidly accumulating Cryo-ET datasets. For easy use, we will develop an open-source GUI α-Tom (to be disseminated into the Scipion and TomoMiner software platforms) that streamlines the new approaches from the initial tomogram reconstruction step to the final subtomogram averaging step. We will validate the performance of our system by applying it on published Cryo-ET datasets and monitor the improvement of the final results.